Integrators of Metastatic Potential

Metastases cause major morbidities and nearly all of deaths in patients with breast cancer and other solid tumors. Our preliminary studies point to an intracellular signaling molecule, GIV, as a central determinant of metastatic potential of breast cancer cells. GIV integrates signals from multiple biochemical and mechanical inputs, placing this molecule as a central hub for key processes driving metastasis. In the parental RO1, we propose to investigate functions of GIV in breast cancer metastasis through a combination of cell-based assays and mouse models. We expect these studies to establish GIV as a potential predictive biomarker and therapeutic target for breast cancer. The research re-entry supplement will support the applicant and her return to a research career. The applicant will participate in all aspects of the proposed research, including planning experiments, analyzing data, and publishing manuscripts. She will learn new experimental methods focused on multi-scale, quantitative microscopy to complement her existing skills in cell and molecular biology. The supplement will enable the applicant to successfully transition back into a successful career in biomedical research.

Public health relevance
The research re-entry supplement will allow Dr. Rehman to return to a productive research career after pausing her career for family reasons. She will participate in all aspects of the parental R01 grant to understand functions of GIV in metastatic breast cancer.